Innate-like CD8+ T-cells facilitate in cardiac remodeling post-MI

Regional myocardial ischemia that leads to injury and myocyte necrosis results in focal scar formation and a
reduction in ventricular systolic function. The constitutive properties of the infarcted myocardium are major
determinants of left ventricular remodeling. The long-term goal of the proposal is to investigate the mechanisms
of cardiac healing and scar composition after myocardial infarction (MI) to provide targets and novel pathways
that drive adverse cardiac remodeling and left ventricular dysfunction. The specific objective is to characterize
the physiological effects of a specialized CD8+ T-cell population termed the innate-like CD8+ T-cells (ILTs) and
dissect how these cells regulate cardiac scar composition and biomechanics after MI. The central hypothesis is
that ILTs decrease (ECM) deposition and alter fibroblast activity via granzyme K (GzmK)-mediated paracrine
signaling through protease activated receptor-1 (PAR1) leading to a less stiff scar. Aim 1 will test the
hypothesis that ILTs are a fundamental determinant of the constitutive properties of ischemia induced
myocardial scar and resulting changes in ventricular structure and function. Aim 2 will test the hypothesis that
one mechanism by which ILTs influence scar biomechanics and LV remodeling is GzmK induced alterations in
ECM degradation. Aim 3 will test the hypothesis that one mechanism by which ILTs inhibit fibroblast activation
is through GzmK induced PAR1 signaling. Our proposed research targets a novel cellular, molecular
mechanism that alters scar properties. Understanding this mechanism behind ILT-mediated effects on
constitutive properties of ischemia induced myocardial scar will provide targets and novel pathways that drive
adverse cardiac remodeling and LV dysfunction. The proposed study aligns with the mission of the VA
healthcare system by providing molecular knowledge to clinical practices so that we can continue to provide
exceptional health care that improves veteran health and well-being.

Public health relevance
Regional myocardial ischemia that leads to myocyte necrosis results in focal scar formation and a reduction in ventricular systolic function. Initially, myocardial and cellular remodeling serve to compensate for decreased systolic function by maintaining stroke volume and systemic perfusion. However, progressive remodeling can become injurious leading to further myocyte loss and decompensation. One pivotal factor that determines the degree to which remodeling occurs is the constitutive properties of the focal scar. Data suggest that there is a direct relationship between replacement scar stiffness and subsequent ventricular remodeling. Therefore, to improve outcomes for Veterans who suffer myocardial ischemia and infarction it is critical and necessary to define the cellular, molecular and biomechanical processes that govern and determine myocardial scar physical properties. Accordingly, we have focused our research efforts on defining the role of one novel cellular mechanism and its molecular determinants in myocardial ischemia induced scar formation.